Core A: Biorepository Core

BIOREPOSITORY/ PATHOLOGY CORE: PROJECT SUMMARY
The Biorepository/Pathology Core will collect and distribute clinically annotated human biospecimens related to
ovarian cancer and will provide pathologic expertise and support for tissue-based analyses for investigators in
the Johns Hopkins-University of Pennsylvania (UPENN) Ovarian Cancer SPORE. The main resource and
operation of this Core will be based on the current Gynecologic Cancer Biorepository (GCB) Bank that has been
a co-joint operation among the JHU Oncology Center, the Kelly Gynecologic Oncology Service in the Department
of Gynecology and Obstetrics, and the Division of Gynecologic Pathology. The GCB bank was established in
2000 and expanded through the support of a US DoD-sponsored program project and subsequently by the DoD-
sponsored Ovarian Cancer Consortium Program. The GCB supports the current Ovarian SPORE Program and
the on-going NCI Early Detection Research Network (EDRN) studies at JHU.
The Cellular Therapy Tissue Facility (CTTF) at UPENN will provide all tissue procurement and processing for
Project 2 (at UPENN) and will procure and process tissue to support Projects 1 and 3 at JHU. The CTTF collects
and processes fresh tumor tissue acquired directly from the operating rooms at the Hospital of the University of
Pennsylvania and Pennsylvania Hospital, as well as from external institutions, including Chester County Hospital.
Tissue will be shared between JHU and UPENN, as well with other collaborating institutions. Thus, the Ovarian
Cancer SPORE Biorepository/Pathology Core will incorporate and build on a pre-existing infrastructure. In the
last few years, the Repository has been expanded to include expert diagnostic pathology and molecular
pathology consultation to investigators, including guidance for quantitative digital image analyses-guided
molecular studies of tissues. Specimens are collected under the supervision of pathologists with expertise in
gynecologic pathology, in close collaboration with gynecologic oncology surgical colleagues. Clinical information
for subjects enrolled in our clinical protocols is entered into a password-protected web-based tracking system,
which follows the recommendations of the National Research Council. A review mechanism is in place for
prioritization of distribution of requested resources to investigators within and external to this Ovarian Cancer
SPORE.